Lifecourse health, cerebral pathology and differences in dementia risk (KHANDLE Study)

The KHANDLE (Kaiser Healthy Aging and Life Experiences [2R01AG052132-06] Study initiated in 2017 is a lifecourse cohort study of differences in risk for cognitive ageing and Alzheimer’s disease and related dementias (ADRD) in elderly individuals. KHANDLE is one of the largest lifecourse cohorts with prospective clinical, lifestyle, and behavioral data from 1964 -present. In Cycle 1, we enrolled 1712 individuals aged 65+ (mean age 76, range 65-103; 60% female) with representation of Blacks, Asians, Latinos, and Whites and 3 assessment waves. We have completed 2 assessment waves, and Wave 3 will finish in May 2021. All waves include comprehensive, psychometrically sophisticated cognitive outcomes, psychosocial measures, residential history, a robust clinical protocol to assess prevalent and incident mild cognitive impairment (MCI) and ADRD and a 25% subsample with amyloid PET and MRI imaging. KHANDLE participants encompasses an array of life experiences; 25% born outside the US, 63% with mothers ≤ high school education, 28% reporting financial problems in childhood, 17% born in Southern States, and 24.8% cognitive impairment at baseline. In this competitive renewal we extend our studies to investigate lifecourse factors related to cognitive trajectories, brain imaging changes, and brain donation based neuropathology. We will continue investigations of incident ADRD, MCI, vascular brain injury changes and amyloid PET taking advantage of imaging in Cycle 1 and repeating in Cycle 2. We will enhance KHANDLE with recruitment of 500 new individuals and will investigate differences in risk by leveraging retrospective data to account for selective survival. KHANDLE is uniquely positioned to address timing of lifecourse exposures and the spectrum of cognitive and cerebropathological aging in a cohort with increased ADRD incidence and cognitive changes in the next 5 years (mean age 81 at start of Cycle 2). Our aims are: Aim 1: Evaluate how life experiences, early- midlife health and development of comorbidities influence ADRD incidence and cognitive trajectories over 9 years. Aim 2: Examine how lifecourse health impacts amyloid PET and structural MRI changes and how neuroimaging biomarkers predict cognitive decline in elderly individuals. Aim 3: Investigate sex differences in ADRD incidence and cognitive decline while investigating the role of selective survival and competing risk of vascular mortality. Aim 4: Initiate a brain donation program for KHANDLE, characterize the spectrum of neuropathology in a lifecourse cohort and evaluate predictors of interest, consent, and participation. Findings from KHANDLE Cycle 2 will uncover mechanisms which lead to differences in risk and resilience to ADRD.

Public health relevance
In 2012 President Obama signed the National Alzheimer’s Plan Act with a primary objective to reduce prevalence and differences in risk and resilience to Alzheimer’s disease and related dementias (ADRD). We propose to continue our unprecedented lifecourse cohort study of late life ADRD and cognitive outcomes, the Kaiser Healthy Aging and Life Experiences Study (KHANDLE). KHANDLE Cycle 1 enrolled 1712 elderly individuals representative of Northern California with the goal of delineating lifecourse drivers of ADRD and cerebropathology. In KHANDLE Cycle 2 we will enroll an additional 500 participants and extend our study outcomes to incidence of ADRD, cognitive decline, brain donation based neuropathology, and changes in neuroimaging based biomarkers of neurodegeneration and vascular brain injury.